Studies of Bacterial Endospore Germination - Adminstrative Supplement

This attachment is not required by the FOA, this placeholder is just to resolve system errors.

Public health relevance
This attachment is not required by the FOA, this placeholder is just to resolve system errors.